A closed-loop gravity infusion control device

Project Summary
This work will develop an innovative infusion device that leverages new electronics and sensor
capabilities to produce a medical device that improves intravenous (IV) infusion delivery. IV
infusions are among most common healthcare procedures administered worldwide; an
estimated 80% of hospital patients receive some IV therapy. Infusions are also increasingly
delivered outside of hospital settings, in homes, long-term care facilities, surge settings and
other alternate site care (ASC) environments. ASC infusions, in particular, are a critical
healthcare trend because they increase access to care by eliminating obstacles such as patient
transportation, pathogen exposure for the immunocompromised, and inpatient costs. While
infusion is critical infrastructure for healthcare delivery, the technologies to deliver it have not
kept up with changing needs in the sector. This proposal builds on a clinically-validated
infusion monitoring system, the DripAssist Infusion Rate Monitor, to create a closed-loop,
digitally-connected infusion platform capable of administering even potentially complex drug
regimes in both acute and ASC settings. This technology-enabled gravity infusion delivery
system with automatic flow adjustment, what we call DripAssist Control, will use low cost
sensors to accurately measure the volume of fluid in a drop. This is an experimental study that
will collect data in silico across a predetermined set of dependent and independent variables.
Large data sets will be collected to which both conventional statistical analysis and machine
learning methods will be applied. Our research will utilize rich information confirmed to be
present in outputs of an existing preliminary benchtop system to establish new data processing
methods for measuring drop volume. Once refined, these methods will be optimized into a
closed-loop flow control system, which will be developed into a form and fit device and tested
within clinical settings with realistic constraints and variability. We have three Aims in this
work. Aim 1: establishing two benchtop systems that can broadly identify the drip volume
rating of an infusion set through a novel detection process. Aim 2: optimize our sensing and
actuating algorithms to clinically acceptable precision and accuracy. Aim 3: perform closed-loop
control system integration and preclinical development work to attain a working prototype
device that can be tested for usability and established regulatory standards. We believe our
work can create a bold shift in clinical practice by introducing novel instrumentation and
sensors and producing a simpler infusion delivery device that matches the precision and
accuracy of expensive pump platforms.

Public health relevance
Project Narrative IV pumps are the gold standard for infusion, but they cannot meet all infusion needs, hence gravity IV infusion continues to be ubiquitous in healthcare. However, there is much room for improvement in gravity infusions, which can result in inaccurate medication administration and adverse effects for patients. In this SBIR project, Shift Labs proposes a game-changing inexpensive, battery-powered device that uses novel sensor technology and algorithms to accurately monitor and control gravity infusions. This will result in a safe, cost-effective device that allows patients to receive best-in-class care in a wide range of healthcare settings, including their homes and surge settings.